Adaptation, execution, and evaluation of a differentiated service delivery model for PMTCT

Project Summary/Abstract
Globally, approximately 1.4 million pregnancies are impacted by HIV every year. In Eastern and Southern
Africa, nearly a third of women living with HIV initiating ART during pregnancy become lost to follow-up (LTFU)
and 29-42% do not maintain viral suppression in the postpartum period. Differentiated service delivery (DSD) is
an evidence-based implementation strategy endorsed by the World Health Organization to improve retention
and viral suppression for people living with HIV. DSD simplifies and adapts HIV services to meet the needs
and preferences of clinically stable clients, allowing for intensification of service delivery to unstable clients who
are most in need. However, DSD models for prevention of mother to child transmission of HIV (PMTCT) are
lacking and data to guide the adaptation of DSD to PMTCT are scarce. The objective of this K23 research is to
adapt, execute and evaluate a DSD model for PMTCT to enhance retention and viral suppression for this
population. The central hypothesis is that retention and viral suppression are driven by a complex interplay of
individual and contextual factors that affect women differently and shape their preferences for services.
PMTCT programs in resource-limited settings can improve outcomes by tailoring service delivery to more
accurately and efficiently meet clients’ needs and preferences using a DSD approach. The specific aims are:
(1) Determine patient preferences for PMTCT services through a discrete choice experiment with pregnant and
postpartum women living with HIV who are retained in care or LTFU, and use these data to identify
components for the DSD model; (2) Develop a DSD model for PMTCT and build organizational readiness for
implementation, using a human-centered design approach that incorporates stakeholders’ perspectives; (3)
Execute a DSD model for PMTCT at one maternal and child health clinic in a resource-limited setting, and
evaluate the model’s implementation using the RE-AIM/PRISM framework. This research will take place at the
Academic Model Providing Access to Healthcare (AMPATH) in Kenya and utilize the research infrastructure of
the East Africa International Epidemiology Databases to Evaluate AIDS (EA-IeDEA) Consortium. In addition to
developing new knowledge, this K23 award will support the career development and training of the PI, Dr. John
Humphrey, so that he can achieve his career goal. His career goal is to become an independent investigator
with expertise in implementation strategies to improve HIV outcomes in resource-limited settings, with a
specific focus on PMTCT. His training aims are: (1) Designing optimized implementation strategies using
discrete choice methodology and integrating data generated through multi-methods research; (2) Executing
and evaluating implementation strategies using implementation frameworks. This K23 will yield an evidence-
based DSD model for PMTCT, filling a major gap in the guidelines and literature for this population. This K23
will also position Dr. Humphrey to develop an R01 to conduct a large-scale trial of a DSD model for PMTCT in
the EA-IeDEA network as an independent investigator.

Public health relevance
Project Narrative Differentiated service delivery (DSD) is an evidence-based implementation strategy to improve retention in care and viral suppression for people living with HIV in resource-constrained settings. The proposed project seeks to develop a DSD model for PMTCT that is user-centered and designed to enhance retention and viral suppression in the PMTCT population. Thus, the proposed project is relevant to the NICHD’s high-priority research focus on adverse pregnancy and infant outcomes related to prevention and treatment of HIV, as well as the broader mission of the NIH to seek fundamental knowledge to enhance health and reduce disability.